Targeted fluorination for improved pharmacology of enzyme replacement therapies

Summary/Abstract: Recombinant protein therapeutics (RPTs) have proven to be an effective method
of treating a growing number of medical diseases/conditions. More than 100 approved RPT therapeutics now
exist, with a potential market expected to surpass $550 B by 2030. Yet despite current success and robust
growth, RPTs tend to be expensive to produce and difficult to administer. Underlying biology can fundamentally
limit the clinical efficacy of a relevant recombinant protein delivered intravenously. Moreover, RPT design has
typically been limited to the twenty canonical amino acids encoded by DNA/RNA triplets. Notably, evidence from
the small-peptide field and from our own preliminary work has established that the substitution of specific amino
acids with “unnatural” fluorinated analogs can increase thermodynamic stability of proteins above native levels.
Thus, Halide Biologics was founded to leverage the potential of chemical biology to enhance the pharmacological
properties of protein therapeutics and to capitalize upon the strong, NIH-funded initial work done by our co-
founders at the University of Iowa and Oregon State University. During this Phase I SBIR project, our
interdisciplinary team intends to establish proof of concept in applying targeted fluorination to the design and
production of novel variants of injectable RPTs in the field of inborn errors of metabolism. Performance will be
compared against relevant standard of care to determine whether targeted fluorination improves the stability of
target proteins to an extent predictive of meaningful clinical improvement. In tandem, we will utilize cutting-edge
techniques for stable integration to generate cell lines that enable production of fluorinated therapeutic proteins
with at least a 3-fold improvement in cost efficiency over the existing transient system. Phase I SBIR success
will lead to the identification of unique engineered therapeutic proteins bearing supra-physiological
pharmacological properties. It will also serve as a foundation for a larger, follow-on Phase II SBIR project that
includes in vivo safety and efficacy profiling. Phase II success will set the stage for a potential Phase IIB project
and/or Phase III commercialization with major industry and/or financial partners. The ultimate commercial goal
of these efforts is the licensing of our novel protein variant(s) to advance the treatment of a wide range of
diseases. Success in the long term will address a major commercial market opportunity and will greatly benefit
the human health and well-being of millions in the U.S. and internationally.

Public health relevance
Project Narrative For many challenging medical conditions (e.g., metabolic diseases, hematologic diseases, and cancer), the best treatment option is the injection of the missing or dysfunctional protein into the bloodstream. Unfortunately, even after four decades, these special recombinant protein therapeutics remain expensive to produce and challenging and inconvenient to administer. For this multi-phase SBIR project, we propose to address this issue by designing, validating, and commercializing next-generation proteins that work better (and/or last longer)—thereby greatly benefitting the health of millions who suffer from a broad range of ailments and conditions in the U.S. and worldwide.